Development of a rapid multiplex CRISPR-based testing pathway for tuberculosis and COVID-19

PROJECT ABSTRACT
Tuberculosis (TB) and COVID-19 (COVID) are currently the deadliest pathogens worldwide, with
1.4 million TB and 2.5 million COVID deaths annually, both perpetuated by potential transmission
from undiagnosed, asymptomatic infection. In the many TB-COVID co-endemic populations in
Asia, sub-Saharan Africa, South America, and Eastern Europe, there is a critical need for
widespread, active, symptom-agnostic screening of TB and COVID to control transmission and
reduce morbidity and mortality. However, the simultaneous burden of COVID and TB poses
enormous stress on these health care systems with severely limited bandwidth and resources for
active case finding and surveillance. Consequently, around 400 thousand more TB deaths are
estimated in the next 5 years compared to prior years as a direct consequence of COVID.
Beyond their global co-prevalence and potential for asymptomatic transmission, TB and COVID’s
overlapping clinical signs and symptoms, risk factors, and shared respiratory transmission
pathways allow for a combined rapid screening approach that can detect both infections using
one sample and testing pathway. This would enable i) more wide-spread screening, ii) at higher
efficiency – fewer individuals need to be screened to detect one TB or COVID infected individual.
We propose to leverage our existing TB and COVID non-invasive samples (eg. sputum,
concentrated saliva, oral swabs), common processing methods and a novel point-of-care
compatible CRISPR-Cas 13 COVID diagnostic system (SHINE) to pilot a streamlined approach
to simultaneously screen for TB and COVID. Specifically, to develop this combined screening
strategy, we will pursue the following aims: 1) transition a point-of-care CRISPR platform for
multiplex screening of TB and COVID, and 2) optimize co-extraction methods from TB and COVID
sputum and sputum specimens. These complementary aims will contribute independent value to
enable streamlined testing and control of both COVID and TB, and are adaptable towards rapid,
multiplex screening and surveillance of future pandemics.

Public health relevance
PROJECT NARRATIVE Tuberculosis (TB) and COVID-19 are leading infectious disease causes of death globally and are co-endemic in many parts of the world with overlapping clinical presentation and risk factors. In these co-endemic regions, comprehensive testing and surveillance for both are often not feasible due to limited public health resources. We propose to pilot a new streamlined CRISPR-based rapid method for testing for TB and COVID-19 simultaneously to enable surveillance for both infections at a fraction of the cost.